Neuroinflammation, Neuronal IL-1R1, and Behavior

Project Summary
Neuroinflammation is a significant contributor to most CNS disorders including neurodegenerative
diseases and psychological disorders. A hallmark of neuroinflammation is the increased expression of the
proinflammatory cytokine interleukin-1 (IL-1) in the brain. How IL-1 causes neuro- and psycho-
pathologies is poorly understood. We have recently discovered that the receptor for IL-1, IL-1R1, is
expressed in specific sets of neurons in the brain. These neuronal IL-1R1s, nIL-1R1, modulate neuronal
activity via non-canonical signaling pathways to alter neuronal function and circuit connectivity. This
application is designed to: 1) map nIL-1R1 distribution in the brain, 2)demonstrate the involvement of
nIL-1R1 in neuroinflammation induced behavioral deficits and neuropathology, and 3) elucidate the
mechanisms of nIL-1R1 mediated neuromodulation.

Public health relevance
Narrative for “Neuroinflammation, neuronal IL-1R1, and behavior” This study investigates the role of nIL-1R1 in mediating neuroinflammation induced neuropathology and behavioral deficits. We will create an atlas of nIl-1R1, demonstrate the involvement of nIl-1R1 in neuroinflammation induced behavioral changes, and elucidate the mechanisms of nIl-1R1 mediated modulation of neuronal function and connectivity.